PSP Omics Center of Acute to Chronic Pain Signatures

PROJECT SUMMARY
This administrative supplement is to continue the ongoing support of the PNNL lead Omics Data Generation
Center (PNNL-ODGC) within the broader context of the A2CPS consortium. Delays within the A2CPS
consortium primarily due to recruitment in the MCC1 and MCC2 clinical site components have facilitated the
extension of efforts beyond the planned timeframe of the A2CPS consortium. Though extensive carry-over
funds have been secured and will be used to extend the analysis timeframe of the PNNL-ODGC efforts, there
still remain gaps in funding based upon current expected recruitment goals, timeframes, and the subsequent
proteomic sample analysis needs. Overall, the objective of the PNNL-ODGC remains, which is to develop and
implement high throughput proteomics-based assays for quantifying a broad and diverse set of molecular
players associated with acute to chronic pain conversion with the goal to develop predictive signatures as well
as inform upon relevant molecular mechanisms. This brings together advanced mass spectrometry (MS)
proteomics capabilities (Pacific Northwest National Laboratory, PNNL) and high throughput screening
capabilities (Luminex Core at University of Pittsburgh Medical Center, UPMC) to accurately detect and quantify
a broad spectrum of primary and secondary marker targets as well as provide a robust proteomic discovery
element for further investigation.

Public health relevance
PROJECT NARRATIVE This administrative supplement is to support ongoing efforts of the PNNL lead Omics Data Generation Center (PNNL-ODGC) within the broader context of the A2CPS consortium. The overall objective of the PNNL-ODGC is to develop and implement high throughput omics-based assays for quantifying a broad and diverse set of molecular players associated with acute to chronic pain conversion with the goal to develop predictive signatures as well as inform upon relevant molecular mechanisms.